Predoctoral Program in Biophysics

Project Summary
The goal of the Yale Biophysics Training Program (BTP) is to equip predoctoral trainees with the intellectual and
research foundations to become future leaders at the forefront of biophysical and biomedical sciences. The
proposed BTP leverages the strengths of our previous 34 year-long program in biophysics training while
incorporating substantial new focuses to adapt to the rapidly evolving research enterprise. The BTP is a PhD-
track program that offers training in a wide range of biological systems and biophysical techniques to enable
understanding the mechanisms of life processes at the molecular level. The BTP combines rigorous research
training in a highly interactive environment and a thorough academic program in biophysics with diverse
opportunities for career and skill development. The program takes advantage of the deep and diverse biophysics
applicant pool at Yale as well as the extraordinary research strengths of 43 faculty trainers from many
departments including Molecular Biophysics and Biochemistry (MB&B), Chemistry, Pharmacology, Immunology,
and Cell Biology. BTP Program Directors Yong Xiong and Elsa Yan work together closely to oversee the program
and together with four additional faculty, constitute the BTP Executive Committee, which develops new initiatives,
evaluates program success based on internal and external reviews, and oversees trainee and BTP faculty
evaluations and appointments. The BTP leadership will additionally ensure that our trainees thrive within an
ethical, inclusive, and safe environment. The principal training entities are the MB&B Department and the
Chemistry Department. Students are admitted to the BTP either directly through the Chemistry Department or
from MB&B Department through an umbrella Biological and Biomedical Sciences (BBS) Program, primarily from
the Biochemistry, Quantitative Biology, Biophysics, and Structural Biology (BQBS) track. Trainees are selected
for BTP appointment in year 2 based on a research focus in biophysics. BTP training involves formal course
work, research rotations, teaching, and qualifying exam in years 1-2, with thesis research beginning in the spring
of year one. Upon joining a mentor lab, dissertation research is performed with supervision from a thesis
committee comprised of at least three faculty that are familiar with the student's research topic and meet regularly
to discuss progress. Training is enriched by intensive coaching in rigor, reproducibility, and responsible conduct
of research, travel to major biophysics meetings, extensive outreach, mentoring, and diversity engagement, and
numerous opportunities for collaboration and interaction. We are also developing special assessment tools and
surveys to measure trainee development and guide future improvements. All trainee outcomes will be deposited
into an easily accessible databank on the BTP website. The training resources at Yale and the dedicated
commitment to training by the mentors, facilitate the BTP goal to produce the next-generation leaders in science.
The BTP requests 12 training positions to appoint 6 second-year and 6 third-year students per year.

Public health relevance
Project Narrative This application proposes to train graduate students to become independent scientists in modern experimental and computational biophysics. This biophysical training is essential to understand the function of all biological macromolecules. This understanding is crucial to deciphering how aberrant biological processes cause disease and this understanding will benefit human health.